Growing Up and Growing Older Across Societies: Harnessing the Power of Comparative Life Course Research Workshop

Project Summary
Scholars have long understood that despite some common features, many key aspects of how
humans grow up and grow older are particulate to one's political, social, cultural, and economic
context. Major investments made in large-scale cohort studies have come to fruition, now
harmonized with cohort studies in other societies or previous cohorts of the same society.
Concerted efforts to make these data publicly available and accessible have produced substantial
documentation, new analytic approaches, and online tools. Yet despite the obvious potentials of
comparative research to move science forward, the actual implementation of comparative
research designs is still at an early stage. Unique challenges to comparative research may hinder
productivity. We propose a workshop on Comparative Life Course Research to address the
unique challenges in comparative research, presented by senior investigators of those cohort
studies (HRS+sibling studies, NLSY, PSID+sibling studies) and featuring exemplar published
studies from junior scholars. Innovations of this proposal include scheduling the workshop
immediately prior the first US-based meeting of the Society for Longitudinal and Life Course
Studies, leveraging additional benefits for workshop attendees including: waived registration for
the SLLS meeting, one-year access to online methodological workshops, and dedicated symposia
to present their own research at the international conference. The specific aims of the R13 grant
are: (1) Assemble national experts in large-scale cohort studies and comparative life course
research to provide a workshop on the cutting-edge trends in the field. [Commitment letters
included in the proposal] (2) Increase the diversity in comparative life course research by
facilitating and assisting scholars from URM groups to attend through travel awards. (3) Build
the research pipeline in life course and longitudinal scholarship by supporting junior scholars
conducting comparative life course research. Case Western Reserve has a strong reputation in
the areas of aging and life course through scholarship, grant funding, and training, making it an
ideal location for the workshop, with the SLLS meeting following immediately at the same
venue. The Co-Investigative team is composed of a diverse (seniority, race/ethnicity, gender)
set of age and life course scholars. A separate Early Career and Student Initiatives Committee
(co-chaired by two Co-Is) is composed of junior scholars from underrepresented backgrounds in
science. Investigators and the committee will be active in recruiting underrepresented minority
researchers to the workshop. The Conference Plan outlines these efforts, as well as resources for
family care and family-friendly programming.

Public health relevance
Project Narrative We seek to host a workshop on Comparative Life Course Research, which would introduce scholars to data and methods to compare health and aging outcomes across societies or between cohorts in the same society. These advanced tools help to inform how we grow up and grow old (e.g., health & disability, family, wealth, education), utilizing high quality longitudinal and cohort studies from around the world. Such inquiry helps us to understand the role of social policy, economics, and cultural influences on health and well-being.